Clinical and Translational Research Services Core

The Clinical and Translational Research Services (CTRS) Core of the University of Washington (UW)
Nutrition Obesity Research Center (NORC) is dedicated to human studies. CTRS Core services fall within 3
service areas: 1) Study Implementation, 2) Imaging, and 3) Nutrition and Physical Activity. Study Implementation
services encompass a range of clinical research support including blood draws and sample processing, research
nursing, research study coordination, and biostatistical analyses. Imaging services include body composition
assessment in humans using dual x-ray absorptiometry (DXA), quantitation of hepatic, intramuscular, and
visceral fat by magnetic resonance imaging (MRI), and specialized imaging using brain MRI to quantify
hypothalamic gliosis. Nutrition and Physical Activity services include menu design, food frequency
questionnaires and dietary recalls, controlled feeding studies, and exercise training and testing. The CTRS Core
provides access to a fully-equipped Clinical Research Unit that was created specifically to support clinical
research in diabetes, obesity, nutrition, and metabolism and is located at the UW Medicine Diabetes Institute’s
combined clinical and research facility. Through a collaborative arrangement with the Fred Hutchinson Cancer
Center that reduces cost and improves access for our Affiliate Investigators, we also leverage a fully staffed
nutrition kitchen for metabolic feeding studies and a nationally-recognized nutrition assessment resource. In this
way, the CTRS Core markedly enhances the clinical and translational component of the UW NORC and serves
the needs of clinical, translational, and epidemiologic Affiliate Investigators across multiple institutions, schools,
departments, and divisions within the large UW system. Interdisciplinary collaborations amongst these
researchers, collaborations with basic science researchers, and utilization of other UW NORC biomedical
research Cores are common and will continue to be actively facilitated during the next cycle. In sum, the newly
created CTRS Core has proven itself capable of meeting the following Specific Aims to: 1) support members of
the research base with cost-effective access to state-of-the-art techniques and resources for nutrition- and
obesity-related research in humans, 2) advance nutrition and obesity science by offering and optimizing
specialized clinical and translational research services, and 3) educate members in the conduct of clinical obesity
and nutrition research and human imaging studies through training, consultation, and collaboration.